The Southwest National Primate Research Center

OVERALL ABSTRACT
The Mission of the Southwest National Primate Research Center (SNPRC) is to improve the health of our
global community through innovative biomedical research with nonhuman primates (NHPs). One way that
it achieves this goal is by serving as a global resource to scientists that can benefit from its expertise and
nonhuman primate colonies. Texas Biomedical Research Institute (Texas Biomed), a private nonprofit
research organization in San Antonio, TX, has a long history of performing biomedical research using NHPs
dating back to the 1950s. Because of its success, Texas Biomed was chosen to host the Southwest National
Primate Research Center in 1999. In doing so, SNPRC became the newest of the NIH funded National
Primate Research Centers. This application for renewed NIH support of the SNPRC highlights the changes
made in response to the reviews from the previous P51 renewal. Specifically, there have been several
critical replacements and hires in leadership. In addition, SNPRC has restructured its internal research
program into two Scientific Units to align with its expertise and future goals. The new Infectious Disease,
Immunology and Control (IDIC) Scientific Unit represents research strengths developed over decades of
primate-based research to bring greater emphasis to these areas. It is already taken advantage this Unit's
expertise to become a leader in SARS-CoV-2 research. Meanwhile the Comparative Medicine and Health
Outcomes (CMHO) Scientific Unit is positioned to be a leader in nonhuman primate research in recently
emphasized research fields including metabolic disease, neuroscience, and aging. Both Scientific Units
perform research with multiple species of primates including macaques, baboons and marmosets and are
integrated into the overarching aims of the SNPRC which include research programs involving NHP models
of human disease not available at other NPRCs. The SNPRC will continue to work towards its mission by i)
To maintain healthy and well-characterized breeding and research colonies of several NHP (NHP) species
for biomedical research, and to make them available to the scientific community; ii) To provide broad
services in primate research to the national research community with an emphasis on specialized
technologies and capabilities many of which are unique to the SNPRC. We provide these services to
enhance collaborative opportunities to both internal and external investigators. Our expertise with diverse
species of NHPs allows us to contribute ideas and perspectives about how best to accomplish the goals of
research projects, thereby increasing the productivity and efficiency of the research, and strengthening the
value of the data derived from it; iii) To maintain and to enhance the physical and administrative
infrastructure of the NPRC so that it can best serve biomedical research. SNPRC has undergone significant
changes in the Administrative structure in the past year. The benefits of these changes to efficiency and
productivity are already apparent; iv) To advance training of staff, students, and visitors in the care and use
of NHPs in biomedical research; v) To contribute to advances in science and translational medicine via
publication of results obtained from research with NHPs and educational outreach to the public.

Public health relevance
OVERALL NARRATIVE The Southwest National Primate Research Center (SNPRC) is hosted by Texas Biomedical Research Institute in San Antonio, Texas. It is one of seven National Primate Research Centers, and the only one hosted by a private, non-profit organization. The Center has more than 60 years of nonhuman primate research experience and through constant improvement and innovation it continues to be a leader in biomedical research.